Understanding Foxp2-Mediated Molecular Signaling in Fear Learning

Project Summary/Abstract
Post-Traumatic Stress Disorder (PTSD) is a common and debilitating mental illness with limited available
personalized treatments. Recent Genome-Wide Association Studies (GWAS) have begun to elucidate
significant target genes implicated in this disease. One of these recently identified targets is the transcription
factor Foxp2. Foxp2 has been previously implicated in language learning disorders, however, its role in adult
fear learning is unknown. In adult mice, Foxp2 mRNA is expressed in clusters of Intercalated Cells surrounding
the basolateral amygdala. Intercalated Cells are functionally important for conditioned fear response and fear
extinction; however, the role of the Foxp2 transcription factor, its upstream mediators and downstream targets,
in modulating fear-related behaviors in the amygdala remains unknown. Recent evidence suggests that Foxp2
is regulated by multiple components of the Wnt signaling pathway and, in turn, acts in a feedback loop to
modulate regulation of Wnt pathway members. In this proposal, I will test the hypothesis that Foxp2 regulates
specific components of fear learning through its interaction with the Wnt signaling pathway in the Intercalated
Cells of the amygdala. In Aim 1, I will test transcriptional regulation of Foxp2 in the amygdala during fear
learning. I will perform a time-course analysis of Foxp2 transcription after fear learning using RT-PCR and
RNAscope. I will also use single nuclei sequencing following Foxp2 knockout to characterize Foxp2 targets in
specific cell types within amygdala after fear learning. Finally, I will perform fear-related behavioral
characterization with amygdala-specific Foxp2 knockout using male and female adult mice. In Aim2, I will
mechanistically test the hypothesis that Foxp2 is regulated by Wnt signaling pathway during fear learning,
building on prior work from the Ressler Lab that showed the role of Wnt signaling pathway components in adult
learning and memory. The outlined K08 proposal will build on my prior experience in developmental pathways,
molecular biology and genetics, while continuing training in a mammalian model of disease-relevant neural
circuitry. The ultimate goal of this proposal is to further my technical and professional skills while collecting
data that will form the basis for obtaining independent funding on a path to becoming an independent
Physician-Scientist.

Public health relevance
Project Narrative Post-Traumatic Stress Disorder (PTSD) is a devastating mental illness with limited treatment options. Recent large-scale genomic studies identified Foxp2 transcription factor as having a significant contribution to this and other psychiatric diseases, however, the molecular mechanisms by which Foxp2 contributes to PTSD symptomatology are unknown. I propose a mechanistic approach to define upstream mediators and downstream targets of Foxp2 within specific cell-types and circuits that are implicated in fear-related behaviors in adult mice.